Administrative Core

The Administrative Core is the mechanism by which decisions of the Executive Committee and the advice of the External Scientific review are operationalized through the Cores and the Project investigators over the five-year funding period. It operationalizes decisions on scientific priorities and goals for the Center, reviews resource allocation and monitors research progress. It is also the avenue by which day-to-day matters, which arise in the context of the operation of individual projects and Cores, can be addressed. Procedures to facilitate these functions and optimize communication have been established in order to allow Directors of the Core groups and the Principal Investigators of individual projects to have ready access to needed information, to permit prompt decision-making on fiscal matters, and to determine and allocate scientific and clinical resources for all projects and cores to achieve the designated scientific goals. This core manages the website. The Core also oversees the Research Training and Summer Research Experience Program. The director of that program is Co-PI for that purpose on Administrative Core. A system for evaluating applicants for summer research electives will select and award eight summer stipends. The program will be publicized and a data base set up to track the future career trajectory of awardees.

Public health relevance
RELEVANCE (See instructions): The Administrative Core oversees all the day-to-day operations of the Conte Center projects and cores for the five year funding period to ensure best use of the resources and adequate resources for project goals and core responsibilities. The Core also oversees the Research Training and Summer Research Program.